Targeted Implementation of Pulmonary Rehabilitation for Post-Tuberculosis Lung Disease

PROJECT SUMMARY
Post-tuberculosis lung disease (PTLD) is a major complication of pulmonary tuberculosis (TB), contributing to
significant impairment and early death among TB survivors in sub-Saharan Africa. Treatment for PTLD is
complicated by the wide heterogeneity in disease patterns which exist. One treatment which reduces PTLD
morbidity across clinical patterns is pulmonary rehabilitation (PR). PR consists of a combination of aerobic
endurance training, strength and resistance exercises, structured education, and behavior change, each of
which can be personalized according to individual characteristics and clinical patterns of lung disease. Yet, PR
is often unavailable in high-TB burden settings due to its resource-intensive and multi-component nature. In
order to make PR for PTLD more widely available in a way that is sustainable in resource-limited settings, we
must 1) define the clinical patterns of PTLD and associated clinical outcomes so we can identify who has the
greatest need for PR, 2) develop a structured process for tailoring PR programs for different settings, and 3)
establish the feasibility and acceptability of a tailored program in a high-TB burden setting. Dr. Navuluri is a
pulmonary-critical care physician with experience in chronic lung disease research in Kenya. She previously
found that routinely available clinical data can be used to identify clinical patterns of disease in a setting where
tools more commonly used for pattern identification, such as high-resolution computed tomography or
complete pulmonary function testing, may not be available. She also found that individuals with PTLD and
health system leaders identify a strong need for PR programs and that adapting individual components and
aspects of PR program delivery can help address the multiple system-, provider-, and patient-level barriers
which exist. To address this need, Dr. Navuluri will use Intervention Mapping for Adaption, a validated, theory-
based framework, to complete three specific aims. In Aim 1, she will employ machine learning methods
(specifically cluster analyses) to identify clinical patterns of PTLD and their impact on quality of life and
functional status using routine clinical data. In Aim 2, she will use human-centered design methods to develop
an implementation blueprint for adapting PR for individuals with PTLD across resource-limited settings and
create an adapted PR program for use in Kenya. In Aim 3, she will conduct a single-arm pilot study to assess
the feasibility, acceptability, adoption and fidelity of an adapted PR program and plan for a future large-scale
hybrid implementation and effectiveness trial. Throughout this work, Dr. Navuluri will learn how to apply
machine learning to inform implementation, use human-centered design to adapt interventions, and design
implementation trials. The proposed studies and training will allow Dr. Navuluri to develop the necessary
skillset for a successful, independent career in implementing evidence-based interventions to improve
respiratory outcomes in resource-limited settings.

Public health relevance
PROJECT NARRATIVE Post-tuberculosis lung disease (PTLD) is a major contributor to reduced quality of life and early death among individuals who have completed treatment for tuberculosis; therefore, interventions to improve PTLD clinical outcomes are needed, especially in resource-limited settings. This project will adapt and implement a tailored pulmonary rehabilitation program involving exercise, education and behavior change strategies among individuals with PTLD. The research in this proposal will directly lead to an implementation blueprint to adapt and replicate pulmonary rehabilitation programs across resource-limited settings and to future trials to improve respiratory outcomes among tuberculosis survivors.